Pathway-specific Intervention in Prelimbic Cortical Circuitry Decreases Cocaine-seeking

Specific Aims
A major challenge for individuals suffering from substance use disorders (SUDs) is the lack of effective
treatments that reduce relapse vulnerability. Drug predictive cues in the environment are powerful triggers for
relapse and understanding how these persistent associations are formed and maintained is a critical focus of
preclinical SUD research. In this proposal, we have built on our discovery that immediately after the end of
cocaine self administration (SA), an infusion of brain-derived neurotrophic factor (BDNF) into the prelimbic (PL)
prefrontal cortex prevents the cocaine SA-induced dephosphorylation of key glutamatergic-related plasticity-
related proteins (PRPs), including GluN2A, GluN2B, ERK MAP kinase, and CREB32,96. This early intervention
with BDNF also prevents prolonged cocaine-induced deficits in PL-NA core glutamatergic transmission that
promote subsequent cocaine seeking9. In contrast, by the end of the first week of abstinence, protein kinase A
(PKA)-dependent augmentation of GluA1 and CREB phosphorylation emerges. At that time, intra-PL BDNF
has no effect on relapse8 but intra-PL infusion of a PKA inhibitor, Rp-cAMPs, reverses the
hyperphosphorylation and decreases relapse70,92. More recently, we have shown that the biphasic changes in
GluA1 and pCREB within the first week of abstinence are associated with similar biphasic changes in the head
diameters (dH) of dendritic spines of PL–NA core neurons89. These data have spurred the overall hypothesis
that interventions to decrease drug seeking must be tailored to the dynamic changes in neuroadaptations that
emerge during different phases of the addiction cycle.
In chemogenetic studies to investigate the contribution of specific pathways originating in PL cortex to drug
seeking, we discovered that PL-NA core and PL-posterior paraventricular thalamic nucleus (pPVT) pathways
oppose each others’ effects during early withdrawal. Selective cre-dependent DREADD inhibition of PL-NA
core neurons infected with a retrogradely transported cre-AAV immediately after cocaine SA has no effect by
itself, but reverses the suppressive effect of intra-PL BDNF on subsequent drug seeking31. In contrast,
selective inhibition of the PL-pPVT pathway immediately after cocaine SA decreases subsequent cocaine-
seeking, an effect that is prevented by intra-PL BDNF31. Interestingly, we also found that selective inhibition of
the PL-pPVT pathway reduces anxiety-related behavior in rats withdrawing from cocaine and inactivation of
pPVT decreases conditioned aversion to cocaine, suggesting that cocaine’s engagement of anxiety- and
aversion-related circuitry that contributes to drug seeking includes pPVT.
Taken together, our new findings suggest the novel hypothesis that cocaine SA produces differential
regulation of PL-NA core and PL-pPVT pathways and that these two distinct circuits conspire to support future
drug seeking. In this proposal, we will use pathway-specific, combinatorial chemogenetic approaches, slice
electrophysiology, and state-of-the-art dendritic spine and PRP imaging in PL-NA core and PL-pPVT circuitry
to explore the time-dependent plasticity occurring in this network that influences cocaine seeking and aversion.
We will use these approaches in the following aims that will be performed in male and female rats.
Aim 1. BDNF regulation of PRPs and structural and synaptic plasticity in PL-NA core vs. PL-pPVT
neurons during early withdrawal. Using viral vector approaches, we will investigate the effects of intra-PL
BDNF infusion on (A) dendritic spine plasticity and PRP changes and (B) synaptic plasticity in PL-NA core vs.
PL-PVT neurons during early withdrawal.
Aim 2. PKA regulation of PRPs and structural and synaptic plasticity in PL-NA core vs. PL-pPVT
neurons after 7 and 30 days of abstinence. (A) We will investigate the effects of inhibiting cAMP/PKA
signaling on (A) dendritic spine plasticity and PRP changes and (B) synaptic plasticity in PL-NA core vs. PL-
PVT neurons after 7 or 30 days of abstinence with or without relapse testing.
Aim 3. The role of PL-NA core and PL-pPVT neurons in cocaine-induced anxiety and aversion in
relationship to cocaine seeking after abstinence. We will use a retro-Gi DREADD approach to test the
effects of inhibiting PL-NA core or PL-pPVT neurons (A) on withdrawal-induced anxiety immediately after the
end of cocaine SA and (B) on conditioned avoidance of cocaine in an operant runway task before or after
cocaine SA followed by cue-induced relapse testing.
Scientific Impact: These studies will expand our understanding of how to reverse critical neuroadaptations
underlying prefrontal dysfunctions during different phases of the addiction cycle that trigger relapse to drug-
seeking. By understanding temporally dynamic, differential neuroadaptations in the PL networks regulating
reward and aversion, we may be able to discover novel therapeutic targets to decrease drug-seeking.

Public health relevance
Despite the critical nature of cocaine addiction, current preclinical models devoted to investigating the enduring neural substrates of cocaine addiction have yielded little insight into developing novel treatment targets. In this application, we focus on distinct, time-dependent interventions during abstinence from cocaine self-administration in male and female rats to normalize cocaine-induced dysfunction in the prefrontal cortex thereby decreasing persistent cocaine-seeking. These studies will impact the field of drug abuse research by advancing our understanding of the key neurobiological substrates that mediate relapse to drug-seeking with the potential of leading to possible novel therapeutic targets for men and women suffering from substance use disorders.